Cardiac Lymphatics in Development and Repair

Project Abstract
Lymphatic vessels serve an essential function in maintaining interstitial fluid balance
throughout the body. Functional disruption of lymphatic vessels by either surgery,
radiation/chemotherapy or organ damage results in pathological lymphedema and subsequent
interstitial fibrous deposition and inflammation. The heart contains a dense network of lymphatic
vessels that exhibit coordinated flow with each contraction of the myocardium. Recent studies,
including our own, have revealed a critical role for cardiac lymphatics in cardiac repair and
maintenance of cardiac function following acute myocardial edema. Several groundbreaking
studies have furthermore shown that cardiac lymphatics arise from at least 4 different progenitor
cell populations, thereby illustrating their distinct and pleiotropic regulation during development
and conditions of remodeling and repair. We have also discovered a significant increase in the
number of cardiac lymphatics of female mice, compared to age-matched male mice, which could
be the basis underlying some forms of cardioprotection in women. Therefore, the overall goal of
this research proposal is to develop sophisticated cell based systems and genetic mouse model
tools to address the function and modulation of cardiac lymphatic vessels in males and females
and during different stages of development and repair. Based on our expertise in lymphatic vessel
biology and our interest in the cardioprotective functions of adrenomedullin peptide, we feel that
we are uniquely well-positioned to address several intriguing hypotheses. Results from our
studies will provide conceptually novel insights into the largely unexplored role of cardiac
lymphatic vessels in heart development, injury and sex-dependent cardioprotection.

Public health relevance
Project Narrative The heart contains a dense network of lymphatic vessels that display coordinated outflow of excess tissue fluid with each contraction. When lymphatic function is compromised, tissues develop edema, which can lead to inflammation and fibrosis. However, it is not clear to what extent cardiac lymphatics, which differ between males and females, contribute to heart development and myocardial fluid balance. Studies proposed in this grant aim to address these questions by using sophisticated cell based and genetic mouse model systems.